Center for Dissemination and Implementation At Stanford (C-DIAS)

C-DIAS OVERALL: PROJECT SUMMARY/ABSTRACT
This is a revised proposal for a NIDA P50 Center of Excellence: The Center for Dissemination and
Implementation At Stanford (C-DIAS). Our overarching goal is simple to say, yet paradigm shifting if
achieved: Equitable access to evidence-based addiction treatments. C-DIAS unites established addiction
dissemination and implementation (D&I) research experts with complementary areas of strength. C-DIAS
Research Core members bring the best of current approaches to D&I science in measures, methods, design
and modeling, as well as in health economics and policy translation. Three coordinated Research Projects
serve as study vehicles to improve D&I science in addiction by reducing variation and increasing
standardization in measures and methods, translating and harmonizing data across studies, and using agent-
based and economic modeling to scientifically respond rather than merely react to substance-related
epidemics and health care disparities.
In addition to serving as the C-DIAS organizational hub, the Administrative Core will provide a platform to
build expert capacity in D&I research in addiction, offering a stratified range of Training Education and
Consultation Services, with open access to online resources and tools for the broadest possible audiences.
C-DIAS will advance D&I science by greater precision and rigor in evaluating implementation
strategies— which are the “interventions” of an endeavor to install or scale up evidence-based treatments.
Proven pharmacological or psychosocial addiction treatments are the “what” of any implementation effort,
whereas implementation strategies pertain to “how” these interventions are most effectively translated and
brought to scale. Policymakers and systems leaders seek empirically-based tools to make informed decisions
about not only what to implement, but how to do so effectively and at what cost.
C-DIAS is based at Stanford but designed to serve as an open, vibrant and highly visible national
center without walls. It will leverage established relationships and generate new connections among
independent multi-disciplinary teams of individuals across geographically dispersed and diverse entities.
C-DIAS will develop human capital, foster synergy, and accelerate professional, scientific and public health
impact with outcomes otherwise unachievable in its absence. We propose a sorely needed and radical
approach, with one critically significant and urgent goal: To improve public health by making the best addiction
treatments equitably available for those most in need.

Public health relevance
C-DIAS OVERALL: PROJECT NARRATIVE In this revised P50 proposal, we envision a Center for Dissemination and Implementation At Stanford: C-DIAS. Public access to (reach) and routine delivery of (adoption) evidence-based addiction treatments are historic and persistent problems. Serving as an open, national and enduring resource, this unique Center of Excellence will integrate broad-based multi-disciplinary expertise, creatively develop expert capacity, advance the science of implementation, and promote the equitable sustainment of proven addiction treatments.